Tolerance to Allogeneic Hearts via Implantation of Cultured Donor Thymus

ABSTRACT: Tolerance to Allogeneic Hearts via Implantation of Cultured Donor Thymus
Advances in immunosuppression have improved patient outcomes after allogeneic heart transplantation, but
patients remain at risk for life-threatening infection, chronic rejection, and end-organ failure. Development of
tolerance to the transplanted heart would reduce or eliminate the need for continuing immuno-suppression,
which should improve both allograft and patient survival. Our goal is to use donor thymus tissue to induce
central tolerance to a heart transplanted from the same donor. We have shown that cultured allogeneic
thymus tissue implantation (CTTI) into athymic children can establish a fully functional immune system that is
tolerant to MHC antigens present on the donor thymus as well as on recipient tissues. We showed that CTTI
can also induce robust donor-specific tolerance in immunocompetent rat recipients of allogeneic hearts
matched to the thymus donor. This project will extend these exciting and potentially paradigm-changing
discoveries to an immunocompetent large animal model where clinical safety and efficacy of tolerance
induction via CTTI can be assessed in preparation for human clinical trials. The specific aims are: 1) To
assess the safety and efficacy of cultured thymus tissue implantation (CTTI) for induction of tolerance
to co-transplanted same-donor cardiac allografts in young miniature swine; 2) To determine the
efficacy of CTTI using thymus from young adult donors for immune reconstitution and tolerance
development in miniature swine; and 3) To develop evidence-based inclusion criteria for expanding the
human thymus donor pool across the age range of potential allograft donors. These studies leverage our
unparalleled expertise in human thymus biology, clinical CTTI, and heart transplantation to induce central
tolerance to transplanted hearts. Results will be applicable to recipients of all types of allografts and should
provide additive or synergistic benefits when combined with tolerance-inducing therapies that act on cells in the
periphery. Together, these studies will advance toward the long sought-after goal of generating the robust
tolerance of transplanted organs that is needed to markedly improve the survival of allografts and recipients.

Public health relevance
Project Narrative/Relevance These studies address critical gaps in the information required to design human clinical trials of cultured thymus tissue implantation (CTTI) as a method to drive immune reconstitution and tolerance to a heart transplanted from the thymus donor. Studies in pigs will define degree of conditioning required, fate of implanted slices, and effects of donor age, while comparative gene expression studies of pig and human thymus tissue will clarify the human donor age ranges that are likely capable of supporting successful CTTI.